SINGLE VERSUS COMBINATION THERAPY TO PREVENT MYCOBACTERIUM AVIUM COMPLEX

This study will compare the efficacy of clarithromycin alone versus rifabutin alone versus clarithromycin plus rifabutin for the prevention or delay of Mycobacterium Avium Complex (MAC) bacteremia or disseminated MAC disease. (ACTG 196)